Data Management and Statistics Core

Data Management and Statistics Core Summary
The Data Management and Statistics Core (DMSC) will foster the Yale ADRC through rigorous collaborative
engagement with investigators, the training of scientists, and the development of novel statistical methodology.
The mission of the DMSC is to provide intellectual leadership and innovation for ADRC research by developing
and applying state-of-the-art data analytic and biomedical informatics, to collect, analyze and integrate data.
Our focus increases collaborative investigation and provides insightful biological and clinical interpretations of
analyses from basic, translational, and methodologic research. The Data Core will 1) provide data
infrastructure to Yale ADRC Cores research and data exchange outside of the Yale ADRC; 2) support the
Outreach, Recruitment, and Engagement Cores; 3) work with the National Alzheimer’s Coordinating Center
(NACC) to continue an efficient exchange of data, support NACC initiatives (UDS4 and digital biomarkers), and
resolve NACC queries; 4) provide comprehensive statistical support (including study design, implementation,
data analysis, and methodology development) to research associated with the Yale ADRC and cross Center
projects; and 5) educate investigators, trainees, and junior faculty in the principles and use of statistical
analysis methodologies. The DMSC works with other Cores and development projects, especially the Clinical
Core to coordinate data management and analytical requirements ensuring rigor and reproducibility. With our
newly expanding real-time data analysis, reports can be generated providing summaries of participants’ UDS
and other data organized by investigator selected characteristics.